PURITY SPECIFICATIONS, STORAGE, AND DISTRIBUTION FOR MEDICATIONS DEVELOPMENT CONTRACT

The Division of Therapeutics and Medical Consequences (DTMC) of the National Institute on Drug Abuse (NIDA)
supports research and development of new medications for the treatment of drug addiction. The objective of this
contract is to provide NIDA and other NIH Institutes (NINDS and NIMH) with a a centralized confidential repository of
compounds for evaluation as potential treatment agents, standards and screening agents.